Advancing the Clinical Translation of Cyst Fluid Assays for Early Detection of Pancreatic Cancer

PROJECT SUMMARY
Pancreatic cystic lesions (PCLs) represent an opportunity for early detection of pancreatic adenocarcinoma.
The accurate identification of cysts with high grade dysplasia or invasive adenocarcinoma, together referred to
as “Advanced Neoplasia” (AN), that warrant surgical intervention represents a critical unmet need in the
management of PCLs. Most pancreatic cysts with the potential to develop AN are mucinous; in contrast, non-
mucinous PCLs have little or no malignant potential. Biochemical and cytological analysis of aspirated cyst
fluid are important tools in the diagnosis and risk stratification of PCLs. However, sensitivity of the only clinical
biomarker for mucinous cysts, carcinoembryonic antigen (CEA), is insufficient to allow clinicians to confidently
remove patients from surgical consideration. Moreover, the most commonly performed CEA assay requires
500 L of fluid, which is often unavailable. For over 50% of patients that undergo invasive trans-gastric cyst
fluid aspiration, inadequate biospecimen is obtained to run the standard of care biochemical tests. In an effort
to improve the sensitivity and applicability of cyst fluid analysis, we used our novel multiplex mass
spectrometry technology to identify the protease gastricsin which accurately identifies mucinous cysts with an
AUC of 0.98 and requires only 5 L fluid. Despite reliance by clinicians on these analyses to guide clinical
decision-making, little effort has been directed toward optimization of biospecimen processing for pancreatic
cyst fluid. There are no standardized pathways for cyst fluid processing and, unlike other biospecimens such
as serum, pancreatic cyst fluid has variable viscosity and contamination with blood and proteinaceous material
that could interfere with assay reproducibility. It is unknown if the variability we observe clinically in cyst fluid
CEA and cytology reflects true biological differences or inconsistent preanalytical biospecimen processing. The
overall objective of this proposal is to improve completeness, reproducibility, and accuracy in
pancreatic cyst fluid diagnostic evaluation in order to improve the early diagnosis of pancreatic cancer
while avoiding the burdens of overdiagnosis and overtreatment. To achieve our objective, we will
systematically evaluate the impact of preanalytical variables on cyst fluid biochemical and cytological analysis
(Aim 1) and identify strategies to mitigate the small volumes of available cyst fluid (Aim 2) in order to develop
a streamlined, reproducible protocol (Aim 3) that improves the reliable early detection of pancreatic cancer.
We will then validate the performance of our streamlined protocol using prospectively - collected clinical
samples, and we will evaluate inter-assay variability by implementing the protocols at two independent sites.
By improving the reliability of our assays, clinicians will be able to direct surgical intervention appropriately to
patients with incipient pancreatic cancer while sparing others unnecessary risks of mortality, substantial
morbidity, and health care costs.

Public health relevance
PROJECT NARRATIVE Despite our reliance on pancreatic cyst fluid biochemical and cytological analyses to guide clinical decision- making for patients with pancreatic cystic lesions, little effort has been directed toward optimization of biospecimen processing for pancreatic cyst fluid. We will systematically (1) evaluate the impact of preanalytical variables on pancreatic cyst fluid biochemical and cytological analyses and (2) identify strategies to mitigate the small volumes of available pancreatic cyst fluid in order to (3) develop a streamlined, reproducible protocol that improves the reliable early detection of pancreatic cancer. By improving the reproducibility and diagnostic yield of our assays for the detection of mucinous pancreatic cysts, we will increase the proportion of patients with pancreatic cystic lesions that undergo complete diagnostic testing, thereby improving the early diagnosis of pancreatic cancer while avoiding the burdens of overdiagnosis and overtreatment.